Travel Support for the International Drug and Alcohol Research Society (IDARS) Meeting

This application seeks funding to enable American junior scientists to attend the next three meetings of the International Drug and Alcohol Research Society (IDARS). The primary goals of this unique meeting are to disseminate cutting-edge addiction-related research findings to a global audience, and to foster international research collaborations. The first IDARS meeting occurred in 2007, and meetings have occurred every two years since that time (with the exception of a one-year delay in 2021). In 2026, the 10th IDARS meeting will convene in Taipei, Taiwan, and the sites of the 2028 and 2030 meetings have not yet been determined. This renewal application requests funds to support each of the next three IDARS meetings (2026, 2028, and 2030). More specifically, we seek funds to support the travel of junior investigators from the U.S. to the next three IDARS meetings, as well as modest administrative support for the activities proposed in this application.

Public health relevance
This application seeks funding to support the travel of junior scientists from the U.S. to attend the next three meetings of the International Drug and Alcohol Research Society (IDARS) in 2026 (in Taipei, Taiwan), 2028, and 2030. The primary goals of IDARS meetings are to disseminate cutting-edge addiction-related research findings to a global audience, and to foster international research collaborations. This award will support travel for junior U.S.-based scientists to this bi-annual meeting, and will facilitate their participation in the global dissemination of cutting-edge addiction-related research findings and international networking among researchers and clinicians working in this area.